Vascular Regeneration with Reprogrammed Endothelial Cells

Project Summary
Ischemic cardiovascular diseases rank among the leading causes of morbidity and mortality worldwide. Despite
advancements in therapeutic approaches, managing patients with peripheral vascular disease (PAD) remains a
formidable challenge. The underlying pathology of these conditions involves vascular loss or dysfunction,
alongside impaired neovascularization, processes primarily governed by endothelial cells (ECs). Consequently,
therapeutic strategies should prioritize regenerating ECs.
To date, conventional therapies have not successfully induced vessel growth in vivo. Thus, cell therapies
utilizing stem or progenitor cells have emerged as promising options to induce neovascularization. However, the
efficacy of adult stem or progenitor cell therapies has been limited. Pluripotent stem cells (PSCs), including
embryonic stem cells (ESCs) and induced pluripotent stem cells (iPSCs), offer a potential source of ECs.
Nevertheless, challenges such as complex differentiation protocols, phenotype maintenance difficulties, and
concerns about tumorigenicity have hindered the clinical translation of iPSC-derived cells.
In response, a novel approach leveraging lineage-specific transcription factors for direct reprogramming
of somatic cells into ECs has been developed. Our research has successfully reprogrammed human dermal
fibroblasts into ECs using ETV2 alone under specific culture conditions. Transplantation of these reprogrammed
ECs (rECs) has demonstrated the ability to induce neovascularization, provide proangiogenic effects, and
improve blood flow in animal models, with the transplanted rECs directly integrating into host blood vessels.
Despite their therapeutic potential, rECs faced limited clinical applicability due to the use of lentiviral
vectors, which can cause insertional mutations. To address this, we developed an adenoviral vector harboring
ETV2 (Ad-ETV2), which is non-integrative and suitable for clinical applications. Using this vector, we successfully
generated rECs from human fibroblasts, showcasing therapeutic potential and neovascularization capability
without genomic concerns. In selecting the source cells for direct reprogramming, we focused on human urine-
derived cells due to their non-invasive collection method, economic viability, and repeat sampling feasibility. Our
developed culture method yields homogenous urine cells expressing mesenchymal stromal cell markers (U-
cells). These U-cells were successfully reprogrammed into rECs using Ad-ETV2, termed U-rECs.
The primary goal of this project is to develop U-rECs into a clinically viable product for treating severe
PAD. In this phase I STTR, we aim to reprogram human U-cells into ECs with Ad-ETV2, assessing their
characteristics, identity, and genome stability. By leveraging non-invasive cell collection methods and a non-
integrative gene delivery system, U-rECs represent a practical and clinically compatible therapeutic option.
Additionally, this product holds potential for applications in tissue engineering, disease modeling, and
personalized medicine, promising a broad impact on research and therapy.

Public health relevance
Narrative Advanced peripheral artery disease (PAD) or chronic limb-threatening ischemia presents a significant challenge as current therapies frequently fall short in providing effects. The overarching objective of this research is to establish a cell-based treatment utilizing directly reprogrammed endothelial cells sourced from patients' urine samples, specifically tailored for addressing this complex disease. Within this grant proposal, our primary focus is on isolating and characterizing the urine-derived cells and their subsequent reprogramming into endothelial cells.